Combating chronic neuroinflammatory disorders by targeting NAC1

Project Summary
Discovery of novel modulatory targets and their modulators would lead innovative strategies for enhancing the
effectiveness of current regimens of for neuroinflammatory disorders such as multiple sclerosis (MS) and is in
urgent need. Recent studies strongly suggest that nucleus accumbens-associated protein-1 (NAC1) may have
an important role in metabolic reprogramming. NAC1 is a transcription co-regulator of the BTB/POZ (broad
complex, tramtrack, bric-a-brac/poxvirus and zinc finger) gene family, and is highly expressed in various immune
cells including T cells. Published studies, including this research team have shown that NAC1 not only bestows
disease potential, but also undermines therapeutic consequence through its transcription-dependent or -
independent functions. Lately, this research team revealed that NAC1 could promote glycolysis through
interacting with HIF-1a and regulate the transcription factor FoxP3, and NAC1 deficiency in mice results in the
resistance to the induction of chronic inflammation and autoimmune disorders. Based on these intriguing
findings, this research team hypothesizes that NAC1 plays a key role in the regulation of regulatory T cells (Tregs)
that modulate the immune system, maintain tolerance to self-antigens, and prevent chronic inflammation and
autoimmune diseases, and that targeting NAC1 could be exploited as a novel strategy for reinforcing Treg-based
immunotherapy for neuroinflammatory disorders. To test this hypothesis, the current application proposes the
following two specific aims: (1) To determine the mechanism of NAC1 in regulating Tregs; and (2) To evaluate the
impact of targeting NAC1 in Treg-based immunotherapy of neuroinflammatory disorders. The research team has
already obtained NAC1 deficient (NAC1-/-) and conditional knockout (NAC1cKO) mice, developed adoptive cell
transfer (ACT) of Tregs and murine models of neuroinflammatory disorders for the proposed studies, and are well
poised to accomplish the above aims. Under the 1st aim, in vitro and in vivo approaches, which have been
established as feasible in the applicant’s laboratory, will be used. The critical roles of NAC1 in regulating Tregs
will be defined. Under the 2nd aim, using ACT of Tregs in which NAC1 is deleted in a murine model of MS, i.e.,
experimental allergic encephalomyelitis (EAE), the most common animal model for brain inflammation, the
impact of targeting NAC1 in Treg-based immunotherapy for neuroinflammatory disorders will be determined.
Furthermore, whether inflammation can alter Treg stability through the upregulation of NAC1 to inhibit FoxP3
expression will also be identified. The approach is innovative, because the concept of targeting NAC1 in
neuroinflammatory disorders has not been previously explored. The proposed research is significant, because
defining the roles and mechanisms of NAC1 in controlling Tregs should yield a better understanding of the
development of neuroinflammatory disorders, and shed new lights on the importance of NAC1 in the regulation
related to neuroinflammatory disorders. The anticipated clinical impact would be the use of the NAC1-targeted
therapeutic strategy to significantly improve the ACT regimen for patients with neuroinflammatory disorders.

Public health relevance
Project Narrative By determining the role and importance of the nucleus accumbens-associated protein-1 (NAC1) in the regulation of suppressor T lymphocytes that are related to the development and treatments of multiple sclerosis, this application wishes to design and develop novel and more effective strategy for improving managements for patients with brain inflammation. The knowledge gained from these studies will provide new insights into the treatments of neuroinflammatory disorders.